Nitrogenase Assembly Mechanism

PROJECT SUMMARY/ABSTRACT Nitrogenase is a complex metalloenzyme that catalyzes one of the most remarkable chemical transformations in biological systems: the nucleotide-dependent reduction of atmospheric dinitrogen to bioavailable ammonia. There is an outstanding interest in decoding the assembly mechanism of nitrogenase, not only because of its significant relevance to nitrogenase-specific reactions, but also because of its tremendous implication for general metalloprotein biogenesis. Here we propose to greatly expand our understanding of the nitrogenase assembly process by combined genetic, biochemical, spectroscopic and structural approaches. The MoFe protein of the molybdenum nitrogenase of Azotobacter vinelandii will be the focus of the proposed investigation. Through our proposed studies, we expect to further refine the biosynthetic pathways of MoFe protein and its associated clusters, a continuous effort with an ultimate goal to unravel the molecular mechanism of nitrogenase assembly. Furthermore, using nitrogenase as a model system, we also hope to provide general themes of biological metal cluster assembly, which may, in the long run, prove instrumental in developing successful strategies for the chemical synthesis of complex metalloclusters. .

Public health relevance
PROJECT NARRATIVE Nitrogenase catalyzes the transformation of atmospheric dinitrogen to bioavailable ammonia, thereby supplying the reduced nitrogen, an essential component of nucleic acids and proteins, for the existence of human population. This particular proposal deals with the assembly of nitrogenase MoFe protein and its associated metalloclusters and the outcome of these studies will hopefully provide general themes of biological metal cluster assembly and facilitate future development of cost-efficient strategies for the chemical synthesis of catalytically active metalloclusters. As such, our proposed research may have additional economic value in addition to its intrinsic relevancy to human health.